1/2 IMPACt-LBP CCC-Administrative Supplements for Complementary Health Practitioner Research Experience

IMPACT-LBP is requesting an Administrative Supplements for Complementary Health Practitioner Research
Experience (Admin Supplements) under Notice of Special Interest NOT-AT-22-010. IMPACT-LBP overarching
goal remains unchanged, which is to refine and implement a multidisciplinary collaborative care model for LBP
(MC2LBP) in 3 academic Health Care Systems (HCS) and then evaluate its effectiveness by comparing it to
usual medical care in patients age 18 and older suffering from LBP. We are currently in year 2/UH3 Phase of
our five year project. This Administrative Supplement is to support our identified candidate, Romeo Perfecto,
DC, MS, CCSP and will serve as a suitable vehicle for his ongoing training in methodology, theories, and
concepts needed to conduct research in complementary and integrative health.

Public health relevance
This Administrative Supplement is to support our identified candidate, Romeo Perfecto, DC, MS, CCSP and will serve as a suitable vehicle for his ongoing training in methodology, theories, and concepts needed to conduct research in complementary and integrative health.